Pilot Effectiveness Trial of THRIVE in Crisis Stabilization Centers: Promoting Connection, Recovery, and Treatment Linkage after Suicide Crisis

Abstract
The US is poised for growth and investment in our mental health crisis system, with a national phone/text
line launching, accompanied by new funding for crisis services. More than 600 Crisis Stabilization Centers
(CSCs) across the US provide suicidal clients with a more comfortable and less costly alternative to
Emergency Department (ED) care. In light of rising demand, there is an urgent need for feasible,
effective, interpersonal, recovery-oriented interventions. This study adapts and tests a novel
intervention for delivery prior to and after discharge from CSCs. THRIVE uses the Interpersonal Theory of
Suicide as a framework to bolster social connectedness and counter perceived burdensomeness.
Preliminary data shows promising results. However, CSC workflows and culture require context-specific
adaptation. This study leverages the Model for Adaptation Design and Impact to adapt THRIVE for CSCs,
test feasibility, acceptability, and appropriateness, and conduct a pilot RCT in two CSCs. The CSC-adapted
intervention addresses interpersonal drivers of suicide risk and bolsters safety, recovery, and community
linkage through: (a) a `belonging and giving' group during CSC stay, (b) recovery coaching calls for 4 weeks
post-discharge, and (c) an optional phone app that provides reinforcement and resources for connection.
The pilot will compare THRIVE + Discharge/Safety Planning (D/SP) to D/SP alone, examining the degree
to which THRIVE engages the targeted mechanisms of change at one- and three-months post-discharge.
Aim 1. Adapt THRIVE and complete CSC-specific manual using MADI.
Aim 2. Test feasibility, acceptability, appropriateness of THRIVE for CSCs.
CSC Guests (n = 20). 75% of guests will participate in a THRIVE group and at least one follow-up
session within one month of discharge. Ratings of acceptability and satisfaction will be ≧ 75%.
CSC Staff (n = 4). Fidelity ratings of audio recordings of group and coaching calls with be at least
≧ 75% for all staff who deliver THRIVE.
CSC Administrators will rate acceptability and appropriateness of THRIVE for CSCs as ≧ 75%.
Aim 3. Conduct a randomized pilot effectiveness trial (n = 162) to assess the effect of THRIVE on
treatment initiation and on key interpersonal drivers of suicide – belongingness and burdensomeness. We
hypothesize that CSC guests who receive THRIVE + D/SP vs. D/SP alone will have:
H1: Higher rates of treatment initiation at 1 month and 3 months from CSC discharge.
H2. Increased belongingness and decreased burdensomeness at 1 and 3 months after discharge.
We will explore the effect of the intervention on treatment engagement, acute care psychiatric
readmissions, and suicidal ideation and suicidal behavior over 3-month follow-up. At the end of the study,
THRIVE for CSCs will be ready to test in an effectiveness trial for preventing suicidal behavior.

Public health relevance
Project Narrative Crisis stabilization centers (CSCs) provide a less costly and more comfortable alternative to Emergency Department care for individuals with acute suicidal crises. With demand for crisis alternatives growing, effective interventions designed and tested for CSCs are urgently needed to realize their life-saving potential. This study adapts and tests the effectiveness of a crisis recovery and follow-up intervention that seeks to reduce suicide risk by strengthening interpersonal connections.